ELECTRONIC COUPLING PROPERTIES OF POLYNUCLEOTIDES

Monitoring the dynamics of rapid photoinduced electron transfer processes enables direct study of the dependence of remote electronic interactions upon the dielectric properties of the surrounding medium. This technique can be used, therefore, to measure electronic coupling and nuclear reorganization energies of biomaterials. However, a proper understanding of electronic interactions between nonconjugated molecular components depends heavily upon the ability to design and build molecular structures that are rigid and whose intercomponent geometry is well defined. All model systems studied to date fail to meet this daunting requisite. Here, we propose a simple strategy that uses polynucleotides, a basic architectural unit in nature, to assemble donor-acceptor (D-A) components into organized units that facilitate study of the electron transporting properties of the host nucleotides. We choose to focus on double- stranded synthetic polynucleotides which readily accommodate intercalating dye molecules with minimum disruption of the biostructure. This innovation approach permits the precise positioning of two electronic partners at predetermined separation distances, ranging from van der Waals contact to over 3 nm, but retaining a fixed orientation. This offers the opportunity, for the first time, to explore mechanisms of electronic interactions involving noncovalent (through space) coupling, an elusive process that has been poorly characterized. A further motivation is that this approach will shed light on the mechanisms of long range electronic tunneling in DNA and thereby provide further understanding of the mechanisms for DNA damage and repair processes. The results originating from this study should have direct relevance for elucidating the mechanisms of rapids biological ET reactions in which proteins or nucleotides function as mediators.